Statistical methods to characterize causal mechanisms by which air pollution affects the recurrence of cardiovascular events

Project Summary
One of our era's greatest scourges is air pollution, and it is well documented that exposure to ﬁne particles (e.g.,
PM2.5) increases the risk of cardiovascular disease (CVD) and death. However, there are two critical knowledge
gaps. First, existing studies have mainly considered the occurrence of the ﬁrst adverse health event as health out-
comes; hence, the impact of overall disease burden and of PM2.5 exposure on disease progression both remain
unknown. Second, to our knowledge, there are no studies assessing the causal pathways by which exposure
to air pollutants impacts recurrent cardiovascular events. Without a better understanding of disease progression
and clinical mediators, our ability to inform regulatory policy and prevent disease is severely hampered.
Limited attention has been given to developing methods for assessing the causal effect of time varying ex-
posures, especially in the presence of a terminating event like death. A related methodological gap is the ability
to identify (time varying) mediators or estimating mediated effects of time varying exposure for a recurrent event
outcome. This proposal addresses these two critical methodological gaps in causal inference, the overarching
goals being to elucidate (i) the impact of PM2.5 on the burden and progression of CVD; and, (ii) the key causal
pathways by which air pollution exposure impacts such events. Accomplishing such goals will be facilitated by
new analyses of an unprecedented data collection consisting of (a) an already harmonized and linked Part A
Medicare data (33+ million subjects 2000 to 2019) at both the individual (e.g., age, gender, race, date of hospital-
ization for any of the possible causes for hospitalizations, date of death) and zip code (e.g., daily PM2.5, O3 and
NO2 levels; many potential confounders) levels; and, (b) an augmented version of these data including individu-
ally linked Part B data (doctor visits, and outpatient procedures for any cause) for a representative sample of over
15 million Medicare enrollees (2012 to 2019) and, (c) the Medicare Current Beneﬁciary Survey (MCBS) data for
the same study period, as a secondary analysis to account for possible bias due to unmeasured confounding.
In methodological terms, we propose robust marginal and structural nested models that allow estimation of
both instantaneous and delayed effects of time varying exposure to PM2.5 on recurrence of CVD events (Aim 1).
We further propose a semiparametric approach to identify clinically important pathways by which exposure to air
pollutants increases the risk of recurrence of CVD hospitalizations and death, and estimate the corresponding
mediated effects (Aim 2). We will implement our methods and apply them to the above-described rich data
source, focusing speciﬁcally on (Aim 3): (i) estimating the causal effects of PM2.5 exposure on two relevant
causal estimands for recurrent events in the presence of mortality; (ii) identifying key mediators and characterize
clinical pathways through which exposure to air pollution increases risks of CVD progression and death; and,
(iii) identifying and investigating the disease groups that are biologically plausible. Finally, we will create and
disseminate open-source, peer-reviewed statistical software to ensure ease-of-use and accessibility (Aim 4).

Public health relevance
Project Narrative This project aims to address the need for robust, rigorous and computationally efﬁcient methods to character- ize causal mechanisms by which air pollution affects the recurrence of cardiovascular events. In general, our approach can be used to estimate the instantaneous and delayed effects of a time varying exposure as well as mediated effects (through time varying mediators) on a counting process. Statistical machine learning ap- proaches will be leveraged to improve confounding control while providing valid statistical inference.